Mechanisms of astrovirus infection

Astroviruses are small, non-enveloped, positive-sense single-stranded RNA viruses (+ssRNA) that are prevalent
in bird and animal populations. Human astrovirus (HAstV) infection has historically been known as a leading
cause of non-bacterial gastroenteritis. However, in recent years, divergent HAstVs have been found in cases of
encephalitis. Despite their prevalence, there is limited information regarding the mechanisms of virus infection.
The virus is known to produce two nonstructural polyproteins required for infection, which are cleaved into
functional subunits by host signal peptidase and the virus-encoded serine protease (Pro). However, the specific
sites of Pro cleavage in the polyprotein have not been discovered. Thus, we do not know the specific sequences
of viral proteins, which has made it difficult to assign functions to these proteins. Similarly, lack of information
and tools has made studying virus-host interactions challenging. Thus, few host proteins that regulate HAstV
infection have been identified. Furthermore, like all +ssRNA viruses, HAstV infection leads to dramatic
remodeling of intracellular membranes to form replication organelles (ROs), which concentrate viral host factors
required for infection. However, the source of the membranes for these critical structures is not well understood.
Overall, there are major gaps in our knowledge of all aspects of HAstV biology and there is a need for tools that
will allow us to build a foundation to expand our research on fundamental mechanisms that regulate HAstV
infection. The goal of this proposal is to utilize tools we have developed for +ssRNA viruses and HAstV to
understand the mechanisms of (1) viral nonstructural polyprotein processing and Pro activity, (2) host protein
regulation of virus infection, and (3) viral protein manipulation of host organelles. We have made significant
progress to be well-suited to accomplish these proposed projects. We have developed a library of polyprotein
expression constructs and a cDNA infectious clone to investigate Pro-dependent cleavage. Additionally, we have
successfully developed a versatile viral protease activity reporter that has been shown to work for enteroviruses
and flaviviruses, which we will adapt for HAstV to study intracellular Pro activity. We have generated tools to
study the microenvironment of the viral nonstructural proteins in living cells and to perform a CRISPR screen for
pro- and anti-viral proteins. Lastly, we have innovative tools and strategies to visualize the manipulation of host
organelles upon viral protein expression or infection using long-term, time-lapse imaging of living cells. Overall,
the proposed projects are designed to significantly advance the field of cell biology of HAstV infection through
investigation of the molecular virology and virus-host interactions.

Public health relevance
Astroviruses remain understudied despite their prevalence in nature, ability to cause disease in humans, and potential for zoonotic spread. Currently, we have a poor understanding of basic viral polyprotein production, interactions with host proteins, and manipulation of cellular organelles required for infection. Thus, the goal of the proposed projects is to take a multi-disciplinary approach to advance our knowledge of astrovirus molecular virology and cell biology of infection.